New Signaling Networks in Vascular Smooth Muscle

Abstract:
This proposal focuses on our discovery of new signaling pathways mediated by the p90 ribosomal S6 kinase
(RSK2) that regulate vascular smooth muscle (VSM) mediated vascular resistance, myogenic tone and blood
flow with the rational that outcomes have potential to deliver new therapeutic targets. The myogenic response of
small resistance arteries is critical for protection of downstream arterioles and capillaries against barotrauma due
to excessive changes in intravascular pressure. Our understanding of the signaling pathways that control
myogenic and agonist-mediated vasoconstriction, vascular resistance and blood pressure homeostasis are
incomplete and this proposal addresses this gap in our knowledge base. Our overall objective is to determine
the contribution of RSK2 to vascular physiology and pathophysiology from a mechanistic and functional
perspective. Our central hypothesis is that RSK2 kinase mediates a novel network of pathways that result in
regulation of VSM contraction in response to myogenic pressure and to agonists. This hypothesis is based on
preliminary data identifying three RSK2 targets in resistance arteries which potentiate the contractile state: (1)
RLC20, leading to direct augmentation of the canonical activation of myosin cross-bridge function; (2) NHE-1
Na+/H+ exchanger, the phosphorylation of which contributes to an increase in pHi associated with an increase
in cytosolic [Ca2+], thereby potentiating the MLCK-mediated pathway; and (3) two RhoA-specific nucleotide
exchange factors, with potential regulatory impact on the RhoA-mediated pathway. Our preliminary data also
suggest that RSK2 signaling contributes ~20% of maximal myogenic force and that arteries from a Rsk2-/- mouse
or treated with RSK inhibitors are more dilated, have reduced myogenic tone and RLC20 phosphorylation and
that Rsk2-/- mice have lower blood pressure compared to wild-type mice. We hypothesize that this non-canonical
RSK2 pathway augments and cross talks with the canonical Ca2+/MLCK and RhoA/ROCK Ca2+-sensitization
pathways to regulate vasoconstriction and basal BP. The following aims test our hypotheses: Aim 1: To
determine how RSK2 contributes to VSM contraction in response to perfusion pressure and agonists, with a
focus on select phosphorylation targets, i.e. RLC20, NHE-1 and RhoGEFs. Aim 2: To assess the contribution of
RSK2 to blood pressure homeostasis. Outcomes are expected to establish and add a new RSK2 mediated
signaling network to the canonical MLCK and RhoA/ROCK signaling pathways regulating VSM tone and
vasoconstriction and to provide possible new therapeutic targets for contractile pathologies of the vessel wall.

Public health relevance
Project Narrative The proposed research is relevant to public health because the discovery of new signaling pathways that regulate blood pressure at the level of contractility of smooth muscle that makes up the walls of blood vessels will contribute to the development of improved therapies for treatments of diseases associated with SM contractile dysfunction such as hypertension and asthma. New drug targets are important as a sizable cohort of patients with hypertension do not respond well to current drugs. Drugs targeting this pathway will be tested in a hypertensive animal model. Such findings are relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to protect and improve health.